Cancer Center Support Grant

This application is being submitted in response to the Notice of Special Interest (NOSI)
identified as NOT-CA-21-100.
Elucidating B cell-mediated mechanisms of response and resistance to radiation therapy in
soft tissue sarcoma
Project Summary/Abstract
Soft tissue sarcoma is a lethal mesenchymal cancer. Radiation therapy remains a cornerstone of
treatment, but the immunologic basis of response and resistance to radiation therapy remains
poorly understood. Historically, research on radiation treatment has largely focused on
methodological issues of its delivery (e.g., optimizing dose and fractionation) and the effects of
ionizing radiation on tumor cells, with less focus on the impact of radiation on the intratumoral
and systemic immune response.
Presumptive immune-mediated consequences of radiation—such as the abscopal effect
and higher incidence of surgical wound infection after radiation—are well documented in the
clinic, but the mechanistic basis of these phenomena are not understood. Here we propose to
longitudinally characterize the human immune response to radiation (e.g. baseline, on-treatment,
post-treatment) in sarcoma patients and further investigate these findings in animal models of
sarcoma. We are particularly interested in the humoral immune response because emerging data
show a strong association between B cells and high antibody titers with response to
immunotherapy and survival in sarcoma patients.
We will provide a comprehensive view of the complex humoral response to radiation
treatment by using a variety of genomic-based, biochemical, and functional assays to gain insight
into the developmental history, phenotype, and function of intratumoral and circulating B cell
populations. This will potentially inform the design of humoral-based therapies that can be used
in combination with radiation treatment for sarcoma patients.

Public health relevance
Elucidating B cell-mediated mechanisms of response and resistance to radiation therapy in soft tissue sarcoma Project Narrative The principal therapy for soft tissue sarcoma is surgery and radiation, but over half of patients will die after treatment for reasons that are not well understood. Prior research has largely focused on the tumor cell-intrinsic effect of radiation, but another possibility is that radiation impacts the immune system in helpful and deleterious ways. Our research program aims to advance understanding of the mechanistic interactions of the immune system and radiation treatment, with the goal of developing novel immunotherapies that can be used in combination with conventional treatments for patients suffering from soft tissue sarcoma.